Insula-BNST Circuit Regulation of AUD

PROJECT SUMMARY
Alcohol use disorder (AUD) afflicts millions of individuals and their families. Current treatment options and
clinical diagnostic tools are limited, necessitating more research on the progression from casual use to AUD in
certain individuals. Identifying pre-AUD biomarkers, as is common practice with heart disease and diabetes,
could impact millions of lives. However, addiction involves complex overlapping patterns that complicate
pinpointing cause and effect, or quantifiable biomarkers, creating an inherent pitfall. Neuronal circuits are the
basic functional units that encode behavior. A better understanding of the neurocircuits engaged prior to
dependence could shift strategies away from reactive treatments, and towards preventative measures to
mitigate risks of developing AUD. Stress is an individualized experience that is highly intertwined with alcohol
use and AUD. Could basal stress activation of AUD-associated neurocircuitry reveal unique patterns that
predict subsequent AUD-related behavior? The insular cortex (insula) is a key network hub for emotional
regulation, salience detection, cognitive control, and sensory processing. Mounting clinical and preclinical
evidence suggests activity patterns in the insula correlate with alcohol drinking behavior. We and others have
characterized a particularly intriguing projection to the bed nucleus of the stria terminalis (BNST), a critical
node for stress-related disorders such as anxiety, depression, and addiction. This circuit is basally quiescent,
but highly responsive to stress, binge drinking, and negative affect in abstinence. A relationship between
stress-induced insula-BNST activation and subsequent alcohol-related behavior has not been examined. We
will test the central hypothesis that stress-induced neuroadaptations in the insula-BNST pathway are
associated with future AUD-related behavior. We predict that a group of stress susceptible mice will exhibit
high insula-BNST stress response and stress-induced neuroadaptations. These changes are expected to
relate to aversion-resistant binge drinking and hyperkatifeia in abstinence, two key features of AUD. Validated
mouse models of stress and binge ethanol drinking will be used to test our hypothesis. Aim 1 will use
longitudinal strategies to examine the relationship between stress-activated insula-BNST circuitry and
binge/aversive ethanol drinking. Aim 2 will identify neuroadaptations within the insula-BNST circuit after stress
and alcohol exposure. Aim 3 will use RNA sequencing to compare the insula-BNST transcriptome after stress
or binge alcohol exposure. Our goal is to identify overlapping transcriptional signatures in stress and AUD-
related behavior. We will mechanistically validate the results with shRNA-mediated knockdown of the top
molecular targets in the insula-BNST to determine their role in binge alcohol drinking. Understanding the
signatures of AUD-related circuits can bridge the gap between molecular and genetic biomarkers, and broader
activity-based digital biomarkers. This conceptually and technically innovative framework will inform improved
diagnosis, intervention, and risk assessment before AUD manifests.

Public health relevance
PROJECT NARRATIVE Why do certain individuals progress from casual alcohol use to alcohol use disorder (AUD) while others do not? We aim to address this question by using preclinical models to examine stress and alcohol-induced adaptations in the insular cortex to bed nucleus of the stria terminalis network, a critical hub for AUD-related behavior. We will determine the role of this pathway in driving two key elements of AUD: compulsive-like drinking and hyperkatifeia during abstinence.